Structural basis of human cytomegalovirus replication within host cells

PROJECT SUMMARY/ABSTRACT
Human cytomegalovirus (HCMV) is a ubiquitous human herpesvirus found in up to 90% of adults. Active
HCMV infection (often referred to simply as CMV by clinicians) can manifest as chronic oral ulcerations and
sialadenitis, and is a major viral cause of birth defects and life-threatening conditions in immunosuppressed
individuals. HCMV is largely innocuous in healthy adults, but for newborns and the immune-compromised,
such as those with AIDS or organ transplant recipients, the dearth of effective HCMV therapies or vaccines
poses a grave risk. HCMV, a member of the β-herpesvirus subfamily of the Herpesviridae, is the most
structurally and genetically complex herpesvirus (e.g., its genome is twice that of chickenpox-causing varicella
zoster virus, an α-herpesvirus). Architecturally similar to other herpesviruses, HCMV virion consists of four
concentric, largely pleomorphic layers: a glycoprotein-decorated envelope, a large, ill-defined tegument layer,
and a bacteriophage-like icosahedral capsid enclosing a dsDNA genome of 230,000 base pairs. In the current
funding cycle, the PI’s group published the cryogenic electron microscopy (cryoEM) and tomography (cryoET)
structures of these layers of HCMV and related β-herpesviruses (human herpesvirus 6 and murine
cytomegalovirus) in a series of high-impact papers and discovered two live-attenuated mutants through
structure-guided mutagenesis with co-I Tang lab (vaccine patent pending). Among them are the first in situ
structures of gB and gB-gH/gL complexes on the HCMV envelope, the atomic structures of the genome-
translocating portal complex, capsid-associated tegument proteins of HCMV and other herpesviruses, as well
as human tRNA bound to the HCMV-specific tegument phosphoprotein, pp150. The renewal application builds
on these successes and harness the PI’s machine learning-empowered cryoEM and cryoET technologies, and
the co-I’s complementary virology expertise, to determine the native structures of the so-far poorly defined
phosphorylated tegument proteins and tRNA interaction in HCMV and to explore their potential roles in CMV
infections. Our central hypothes is that HCMV packages a myriad of molecules—including human tRNA and
switchable phosphoproteins—and release them to modulate immune systems and promote replication within
host cells. First, we will define cell-line specific recruitment of human tRNA by the CMV-specific tegument
protein pp150 and explore the roles of virion-containing human tRNA in replication (Aim 1). Second, we will
obtain native atomic structures of pp65, pp71 and by structure-guided mutagenesis, elucidate critical
interactions within the HCMV tegument, focusing on the phosphoproteins pp150, pp65, and pp71 (Aim 2).
Finally, by AI-empowered cellular cryoET, we will define how uncoated HCMV particles with inner tegument
proteins undergo microtubule-guided retrograde transport and dock at nuclear pore complexes to facilitate
genome ejection into the nucleus (Aim 3). The expected results will elucidate the mechanisms of tegument
protein-host interactions governing viral replication and inform efforts to develop anti-HCMV therapies.

Public health relevance
PROJECT NARRATIVE Active cytomegalovirus (CMV) infection can manifest as chronic oral ulcerations and sialadenitis, and is a major cause of birth defects and life-threatening conditions in immunosuppressed individuals (e.g., the elderly, organ-transplant recipients, and people with AIDS). The atomic structures and infection mechanisms from this project will reveal how the virus interacts with our cells to cause viral spread. The results will also uncover novel targets for antiviral drug design and engineering strategies for vaccine design against HCMV infection.